Diversity Supplement - Genetic Basis of Congenital Anophthalmia

PROJECT SUMMARY Anophthalmia, microphthalmia and coloboma (MAC) are birth defects in which the eyes are absent or very small, or where the choroid fissure fails to close in the optic cup. Most cases are sporadic, but Mendelian pedigrees have been described, typically with low penetrance. Few genes have been identified, encoding transcription and growth factors (e.g. SOX2, BMP4) active during early eye development. Most cases are unexplained. Maternal nutrition may contribute to the etiology. We found that mutations in 3 retinoid (vitamin A) pathway genes (RBP4, STRA6, ALDH1A3) account for >5% of MAC cases, including a new gain-of-function mechanism for this disease. The RBP4 alleles encode dominant-negative serum retinol binding proteins, which bind retinol cargo poorly but adhere to the STRA6 cell surface receptor too tightly (40-fold higher affinity) — so may disrupt retinol transfer across the yolk sac and placenta, to the embryo. The dnRBP4 mutations define a new mode of maternal inheritance and illuminate a critical protein- receptor interaction. In addition, clustered STRA6 point mutations suggest a new domain function for this polytopic receptor. We will investigate the mechanism for increased RBP affinity and critical features of the RBP-STRA6 interaction, and test the receptor comp- etition model for MAC pathogenesis [ 1 ] in vitro and [ 2 ] in vivo, using a comprehensive biochemical, cell-based, radioisotopic and histological approach, mouse models with specific knock-out or genome-edited (CRISPR/Cas9) alleles, and dietary manipulation. In addition, [ ] we will systematically screen a cohort of MAC patients using exome 3 sequencing (WES) and segmental dosage (SNP) analysis to find causative mutations in new genes, and will explore the developmental basis in compelling cases. One example is BASR (bilateral anophthalmia with sex reversal), arising from an X-autosome translo- cation, with trans-fating of RPE to neural retina as a potential mechanism. We will test this hypothesis in vitro (chromatin topology and iPSC differentiation assays) and in vivo (specific transgenic mice).

Public health relevance
NARRATIVE We will investigate gene defects in children whose eyes are absent (anophthalmia), very small or malformed (coloboma), using biochemical methods, mouse models and genome sequencing. Our study is centered on new mutations that appear to block retinol (vitamin A) transport or metabolism, or the separation of neural and pigmented layers in the developing retina; as such, we will test new models for hereditary disease, establish a nutritional basis for maternal inheritance of phenotypic traits in pedigrees, and explore the earliest steps in eye formation. The results should improve diagnosis and understan- ding of eye malformations, and complex genetic factors underlying birth defects.